Copper and iron in nutritional immunity

The objective of this proposal is to elucidate the mechanisms by which the copper­containing ferroxidase, ceruloplasmin, regulates nutritional immunity against bacterial infection. There is an urgent need to understand mechanisms of nutrient homeostasis in order to develop more effective treatments and therapies. Nutritional immunity describes mechanisms that alter host metal ion homeostasis during microbial infection. An important aspect of nutritional immunity is iron withholding from bacterial pathogens via hypoferremia (low plasma iron levels). Hypoferremia is regulated by peptide hormone, hepcidin, which restricts iron export into the plasma by inducing the degradation of the iron exporter, ferroportin in hepatocytes, enterocytes and macrophages. Another mechanism of nutritional immunity involves hypercupremia (high plasma copper levels). This process occurs via increased hepatic secretion of ceruloplasmin, a copper carrying ferroxidase that contains the majority of copper in the plasma. Copper is thought to facilitate killing of bacterial pathogens via macrophages of the innate immune system, however, the role of ceruloplasmin in this process is unknown. Despite its identification as an acute phase protein more than 60 years ago, the requirement for ceruloplasmin during infection remains unknown. As a ferroxidase, ceruloplasmin facilitates iron export via ferroportin, however, this function is unnecessary during infection due to ferroportin degradation. Thus, it is likely that ceruloplasmin has alternative functions during infection. Preliminary results demonstrate that ceruloplasmin knockout mice are highly susceptible to systemic infection by the bacterial pathogens Salmonella typhimurium and Staphylococcus aureus. In addition, ceruloplasmin knockout mice were found to exhibit reduced serum levels of proinflammatory cytokines when challenged with bacterial ligands to Toll­like receptors (TLRs), highlighting a possible role for ceruloplasmin in TLR signaling. In this proposal, biochemical and genetic approaches will be used to understand the contribution of ceruloplasmin to nutritional immunity. AIM1 tests the role of iron and copper on hypersensitivity of ceruloplasmin-­null mice to infection. AIM 2 seeks to understand the role of ceruloplasmin in TLR signaling within macrophages. AIM 3 investigates whether macrophage or hepatocyte expression of ceruloplasmin is required for host immunity.

Public health relevance
Nutritional immunity, which plays a part in host defense against microbial infection, include regulating levels of iron and copper in the body. Ceruloplasmin, a copper-carrying protein in the blood, is elevated during infection, and may play novel roles in controlling copper and iron to fight bacterial infection. Our goal of understanding the role of ceruloplasmin in nutritional immunity may lead to better ways to prevent and fight infections.